Squirrel Monkey Breeding and Research Resource

PROJECT SUMMARY: OVERALL COMPONENT
This application is a competing renewal of the “Squirrel Monkey Breeding and Research Resource”
(SMBRR) P40 OD010938 which has received continuous NIH grant support since 1980. The SMBRR is the
only national research resource of squirrel monkeys available to NIH grantees, intramural research programs
of federal agencies including the FDA, NSF, and the NIH, and other sponsors of biomedical research (private
foundations, pharmaceutical companies, and contract research organizations). Because Bolivian squirrel
monkeys are no longer available from source countries, and there are no other breeding colonies of pedigreed
squirrel monkeys available for biomedical research, the SMBRR is a unique research resource that cannot
be duplicated or replaced. The scarcity of squirrel monkeys, difficulties associated with captive breeding, as
well as the challenges associated with their care and use in research, all contribute to the need for this national
research resource. The SMBRR has integrated multiple disciplines into a program designed to meet the needs
of investigators who utilize its resources. In the upcoming years, the SMBRR will continue to improve the
resources it provides and continue to add new information about the biology and research value of squirrel
monkeys. Squirrel monkeys continue to be an important animal model in neuroscience research, drug
addiction research, malaria vaccine research, and fundamental evolutionary biology. Over the next five years,
the SMBRR will focus on refining the animals and related resources to meet the needs of the scientific
community. The aims of the Resource Core Component address our continued commitment to meeting the
needs of the research community for access to squirrel monkeys and information about using squirrel monkeys
in research. We will explore the causes of perinatal mortality in a retrospective epidemiology study. We will
produce a long read genome sequence from a Saimiri boliviensis boliviensis and extend our BioBank to
include specific DNA sources from the resource. The Applied Component research projects focus on basic
research projects that will enhance biomedical models using squirrel monkeys. These studies include defining
and characterizing the different classes of monocytes in squirrel monkeys, as well as characterizing the gut
microbiome in differing age classifications of animals. We will also begin to test memory in our adult and
geriatric squirrel monkey populations using computer assisted learning methods. The overall goals of the
SMBRR are to provide a national research resource of squirrel monkeys; provide squirrel monkey
derived biological materials; provide education and training opportunities to scientists wishing to work
with squirrel monkeys, colony managers, and animal caregivers; and provide investigators with
facilities and expertise to conduct studies using squirrel monkeys.

Public health relevance
PROJECT NARRATIVE: OVERALL COMPONENT The “Squirrel Monkey Breeding and Research Resource” (SMBRR) maintains the only self-sustaining national research resource of laboratory-born squirrel monkeys, their tissues and other biological materials, as well as the expertise to carry out research on this important research animal. Scientists with NIH grants utilize squirrel monkeys to study many diseases that threaten human health including Alzheimer's disease and other disorders of the central nervous system, drug addiction, malaria, and viral diseases. The definition and quality of the SMBRR's resources have reduced the number of squirrel monkeys needed, and in some cases, biomaterials from the SMBRR have reduced or eliminated the need for living animals to accomplish research goals.